Heterosubtypic immunity to influenza virus mediated by MHC-E-restricted memory NK cells

Seasonal influenza epidemics are a leading cause of morbidity and mortality worldwide, and while prophylactic
immunization has proven the most efficient way to prevent influenza so far, current vaccines provide limited
protection against antigenically distinct influenza strains, notably those with pandemic and/or high pathogenic
potential. Therefore, innovative approaches to provide longer-lasting protection than currently licensed vaccines
and against a wider variety of influenza viruses is highly desirable. Mobilization of immune effector cells with
potent antiviral activity against conserved influenza antigens represents one strategy to enhance cross-
protection. Classically, Natural Killer (NK) cells are viewed as nonspecific effector cells of the innate immune
system that play critical roles in defense against viral infections, including influenza. Unexpectedly, for over a
decade, paradigms suggesting that immunological memory is exclusively mediated by T and B cells have been
challenged by several independent studies clearly demonstrating that subsets of murine, non-human primate
(NHP) and human NK cells are capable of adaptive immune functions, including antigen-specificity and recall
responses. Our new preliminary data now show for the first time that influenza-specific NK cells mediating potent
responses against conserved influenza antigens from serologically distinct strains exist in humans and provide
mechanistic evidence supporting a role for HLA-E and its activating ligand NKG2C in antigen-specific NK cell
responses. Collectively, these findings suggest that vaccine strategies that concomitantly enhance the breadth,
magnitude and cross-reactivity of influenza-specific memory NK cell, T cell and B cell responses might
significantly improve vaccine-induced cross-protective immunity. However, mechanisms underlying the
establishment and maintenance of true antigen-specific NK cell memory are largely undefined and protection
mediated by influenza-specific memory NK cells remain to be determined in primate species. In this study, we
propose to address the overarching hypothesis that MHC-E-restricted memory NK cells can mediate
heterosubtypic protection against influenza through three focused independent Aims: (i) Characterize
human influenza-specific memory NK cell responses; (ii) Assess influenza-specific memory NK cell-
mediated cross-protection in macaques; and (iii) Delineate MHC-E-restricted NK cell antigen specificity
against influenza. We expect these innovative studies to help develop universal influenza vaccines tailored to
mobilize influenza-specific memory NK cells.

Public health relevance
Currently licensed influenza vaccines need to be reformulated each year and have limited efficacy against new influenza viruses that can cause severe disease and high mortality. This proposal is designed to test the hypothesis that in people who have been exposed to influenza virus, a subset of long-lived natural killer (NK) cells can specifically recognize a broad range of different influenza strains and confer protection against new influenza viruses. The outcome of these investigations will provide the rationale to harness NK cells in future universal influenza vaccines.